Rapid structure-based software to enhance antibody affinity and developability for high-throughput screening

Therapeutic monoclonal antibodies bind to specific regions of proteins called epitopes, which elicit cellular
responses that treat or cure disease. Discovering therapeutic antibodies traditionally requires laborious and
expensive screening experiments, so computational approaches that select which antibodies bind an epitope
best and have the most desirable pharmaceutical properties are in high demand. Structure-based antibody
design is also important to the modern drug discovery and development process. This approach requires a high-
resolution quaternary (3D) protein complex structure, whose experimental determination is often a slow process
that is not always successful. Protein structure and binding interface prediction algorithms are poised to impact
human health by accelerating the construction of high-confidence structural models of drug targets and
biopharmaceuticals, which will help identify new therapeutic strategies. However, the current algorithms are
limited in their ability to distinguish stronger-binding antibodies from weaker ones, which is preventing the
discovery of broad classes of therapeutics. In addition, technologies are needed to predict if a candidate antibody
will fail as early as possible in the development process. With improvements in simulating removal of molecular
liabilities without damaging function, computer-aided antibody design can be used to lower drug development
costs and focus experiments on the most promising drug candidates.
Here we propose to advance antibody discovery by developing highly accurate software tools built on the
success of DNASTAR’s NovaFold Antibody program for antibody structure prediction, NovaDock for flexible
protein-protein docking, and Lasergene Protein Design for protein engineering. The aims of the project focus 1)
on developing more accurate and effective immune complex (an interacting antibody and antigen) structure
predictions through better modeling of the challenging complementarity-determining regions (CDR), which play
a critical role in antibody affinity and selectivity; and 2) on predicting antibody sequences that reduce chemical
and energetic liabilities that prove detrimental to an antibody’s manufacturing process or therapeutic effect in a
patient. In particular, overall predictive capability will be improved by incorporating computational acceleration
techniques to support the virtual screening of tens of thousands of antibody sequences. Finally, and for the first
time, this project will develop a “virtual immune system” to approach human antibody discovery, where antibodies
will be modeled from germline sequences and selected for best recognizing an antigen of interest. The overall
project goal is to deliver an advanced antibody screening pipeline that is powerful, accurate, and produces fast
results, which will accelerate antibody discovery by enabling detailed and accurate immune complex structure
predictions and structure-based liability detection at a high-throughput scale.

Public health relevance
Antibodies are invaluable biotechnology tools for diagnosing and treating human diseases; they have been used to detect drugs, toxins, hormones, or pathogens; perform tissue typing; suppress organ transplant rejection; and therapeutically treat viral infections, cancer, and autoimmune diseases. In this project, we will develop a pipeline to replace a large portion of costly, time-consuming experimental work required today in antibody drug discovery with a software pipeline based on improvement in and integration of protein structure prediction, protein-protein docking and protein engineering tools we currently provide to the market. Our proposed pipeline will be poised to accelerate antibody drug development and reduce costs of antibody drug discovery by 80 – 90%, literally revolutionizing the way antibody discovery and development is performed by biotech and pharmaceutical companies and third-party contract research organizations.